BLRD Senior Research Career Scientist Renewal Application

Project Summary/Abstract: Role of hypocretin in opiate addiction and withdrawal
Major causes of the opiate crisis are the addictive nature of opiates and the negative physiological and
psychological effects of withdrawal that lead to relapse. These effects persist for months or years after the last
dose is taken. In recent work we have found what may be the largest change in neuronal morphology in the
brain of human heroin addicts; an average 54% increase in the number of neurons producing detectable
levels of hypocretin (Hcrt, orexin), and an average 32% shrinkage in the volume of hypocretin neurons.
Adjacent melanin concentrating hormone neurons do not change in number or size. We saw a similar long-
lasting increase in the number of detected hypocretin cells and a shrinkage of these neurons, accompanied by
elevated levels of brain hypocretin, in wild-type mice after longterm, but not short term, morphine
administration. The increase in hypocretin cell number is not due to neurogenesis, but rather to increased
production of hypocretin in neurons that do not produce detectable levels of these peptides under baseline
conditions. Our pilot data, using a newly developed transgenic mouse in which hypocretin neurons can be
selectively deleted (DTA-Hcrt mice), shows that removal of hypocretin neurons greatly reduces withdrawal
symptoms and the expression of the molecular markers Fos and DeltaFosB in addiction related regions.
These preliminary findings suggest that a blockade of hypocretin receptors, a decrease in of the activity of
hypocretin neurons, or a reduction of elevated hypocretin neuronal number back to baseline levels would aid
in withdrawal and prevent relapse in human opiate addicts. We propose to identify the opiate receptors
responsible for the changes in hypocretin cell number and size. We will record from hypocretin neurons in
freely moving animals using our chronic unit recording technique to determine, for the first time, how the
response of these cells to systemic morphine changes with addiction and withdrawal. We will determine how
the newly identifiable hypocretin producing cells induced by opiate administration differ from the baseline
population in distribution, projection, and co-transmitters. We will determine the changes in the receptor and
membrane physiology of hypocretin neurons produced by opiates using in vitro techniques. In our prior
work we found that human narcolepsy is caused by an average 90% loss of hypocretin cells. Of great interest,
is that human narcoleptics rarely abuse or escalate dosage of therapeutic drugs, even though the
amphetamines, methylphenidate and gamma hydroxy-butyrate that they take daily to reverse symptoms are
frequently abused in the non-narcoleptic population. The increased activity of hypocretin neurons that we
find in mice after morphine administration, the greatly increased number of hypocretin cells in human
addicts, and the greatly decreased number of hypocretin cells in narcoleptics, who are resistant to
drug addiction, suggests that hypocretin neurons have a major role in maintaining opiate addiction and
relapse. Manipulation of hypocretin neurons may be the key to facilitating withdrawal in addicts.

Public health relevance
Project Narrative: Role of hypocretin in opiate addiction and withdrawal We have recently found an average 54% increase in the number of hypocretin (orexin) producing neurons and a 32% shrinkage of these neurons in human heroin addicts. This is the largest change that has been reported in neuronal morphology in opiate addiction. We plan to determine the cause of this change and test the hypothesis that this increase causes, and can be manipulated to prevent or attenuate, the opiate withdrawal syndrome.